Characterizing longitudinal dynamics of indeterminate pulmonary nodules using semantic, radiomic, and deep features

This application is being submitted in response to the Notice of Special Interest (NOSI) deﬁned as “NOT-CA-24-058”.
Landmark studies such as the National Lung Screening Trial (NLST) demonstrated that low-dose computed
tomography (LDCT) screening reduces lung cancer mortality, but the growing use of LDCT has also led to the annual
discovery of over a million indeterminate pulmonary nodules (IPNs), which in the context of this project are solid
noncalciﬁed nodules between 6-30 mm in diameter. While IPNs are largely benign, their discovery induces anxiety
among patients, creates a burden on the healthcare system, and, for some patients, represents early-stage cancer.
Newer imaging-based biomarkers and the use of the patient’s evolving medical history can improve prediction and
support earlier diagnosis in the setting of the IPNs. Key challenges to overcome include handling variations in how
CT studies are acquired, characterizing and modeling changes in nodular and perinodular features observed over
longitudinal imaging scans, and predicting whether an IPN is malignant. This supplement utilizes longitudinal
clinical and imaging data collected as part of the NLST but addresses several critical limitations: (1) nodules were
not uniquely identiﬁed, (2) nodules were not tracked over multiple scans, (3) the precise location of nodules and
their boundaries were not delineated, and (4) lung cancer diagnoses were not linked to individual nodules. This
project complements the parent U01 (EFIRM Liquid Biopsy Research Laboratory: Early Lung Cancer Assessment,
U01 CA233370, Contact PI: Wong), which seeks to develop and validate a blood-based technology to distinguish
benign and malignant IPNs. Our overarching hypothesis is that the combination of longitudinal semantic
(radiologist-interpreted), radiomic (e.g., handcrafted shape, intensity, and texture), and deep (e.g., neural-network
learned) features can predict nodule malignancy among IPNs with higher positive predictive value than nodule
volume alone. We will investigate whether the change in these features (delta image features) captures the natural
history of tumor and peritumoral appearance, hypothesizing that these subtle changes reﬂect shifts in the tissue
microenvironment and can be used to di]erentiate between benign and malignant nodules. We accomplish this
with two aims: (1) characterize longitudinal changes in nodules using semantic, radiomic, and deep features and (2)
assess the predictive value of longitudinal features in classifying IPNs. We have established a team of investigators
with expertise in liquid biopsy, machine learning/informatics, and thoracic radiology. Our e]orts will collectively
result in a comprehensive annotated dataset of NLST IPN cases as they evolve and the identiﬁcation of delta image
features that can be surrogate endpoints for clinical trials and physician support services.

Public health relevance
Lung cancer remains the leading cause of cancer-related deaths in the United States. While new low-dose com- puted tomography (LDCT) screening programs nationwide enable earlier detection of lung cancer, a high number of indeterminate pulmonary nodules (IPNs) are being found – many of which are benign, but still with some risk of cancer. This supplemental project aims to leverage the large collection of longitudinal clinical and imaging data on individuals who underwent LDCT as part of the National Lung Screening Trial with established cancer outcomes to identify robust longitudinal imaging biomarkers that can be used to predict malignancy, reducing overtreatment and the burden and anxiety associated with managing IPNs.